Harnessing the CARD8 Inflammasome for HIV Reservoir Elimination

PROJECT SUMMARY
The HIV-1 reservoir is a stable pool of latently infected CD4+ T cells that rekindles viral replication even after
decades of antiretroviral therapy (ART). ART alone is not curative, requiring life-long treatment for people living
with HIV-1 (PLWH). The main strategies attempted so far to eliminate HIV-1-infected cells face multiple
challenges, including the selection of escape variants, resistance to apoptosis, T cell exhaustion, downregulation
of MHC-I by HIV-1, and localization of infected cells in immune sanctuaries. This research program has the long-
term goal of developing new therapeutic approaches to eliminate or control the HIV reservoir, leading to a drug-
free remission. We recently discovered that the inflammasome protein CARD8 senses the enzymatic activity of
the HIV-1 protease. We demonstrated that non-nucleoside reverse transcriptase inhibitors (NNRTIs) such as
efavirenz (EFV) promote dimerization of Gag-Pol and cause premature intracellular activation of protease. HIV-
1 protease cleaves CARD8 driving the formation of caspase-1-dependent inflammasome and pyroptosis. All
clinical HIV-1 isolates can be sensed by CARD8 despite viral diversity because it recognizes essential protease
functions. The overall objective of this application is to harness CARD8 inflammasome to develop a novel
approach to enhance HIV-1 reservoir elimination independently of CTLs or antibodies and trigger cell killing
through non-apoptotic cell death. The underlying central hypothesis is that EFV-induced activation of CARD8, in
combination with CARD8-enhancing drugs, can clear cells with transcriptionally active proviruses, reduce viral
reservoir expansion, and gradually remove proviruses integrated into euchromatin regions. The rationale for the
project is that enhancing the negative selection forces will reshape the proviral landscape, accelerate its decay,
and reduce viral reactivation. The central hypothesis will be tested by pursuing three specific aims: 1) Establish
EFV-induced CARD8 activation and killing of expanding HIV reservoir cells upon stimulation with cognate
antigens ex vivo; 2) Determine the impact of EFV on HIV-1 reservoirs in humanized mice; and 3) Investigate the
impact of EFV on HIV-1 reservoirs in PLWH in vivo by studying banked samples from clinical trials. The research
proposed in this application is innovative because, compared to the status quo, it focuses on a new mechanism
independent from HIV-1 diversity and cell susceptibility to apoptosis. The proposed research is significant
because it is expected to provide the groundwork for the development of a new curative strategy that is scalable,
broadly applicable in different contexts of clinical research, and can be easily combined with other interventions
aiming to achieve HIV-1 remission. At completion, the proposed work will inform future pre-clinical and clinical
research on the development of new antiretroviral compounds that can potently eliminate HIV-1-infected cells
by activating CARD8-sensing of HIV-1 protease activity.

Public health relevance
PROJECT NARRATIVE In the absence of new therapeutic strategies, the goal of providing universal HIV-1 treatment and ending the HIV-1/AIDS epidemic is unattainable. HIV-1 persists in a stable reservoir of latently-infected cells, representing the major obstacle to achieving HIV-1 remission. As part of NIH’s mission to end the HIV-1 epidemic, this project seeks to understand whether the CARD8-inflammasome can be harnessed to eliminate infected cells, which may lead to control of HIV-1 without the requirement for lifelong treatment.